Interventions that Address Structural Racism to Reduce Kidney Health Disparities Research Coordinating Center

PROJECT ABSTRACT
Recognizing the significant impact of structural racism on kidney health in minority populations, the
NIH is creating a new Consortium focused on Interventions that Address Structural Racism to Reduce
Kidney Health Disparities. The Consortium will bring together research teams from six Intervention
Sites to conduct community-engaged intervention studies to address structural racism and reduce
disparities across the spectrum of kidney health and disease. We propose to serve as the Research
Coordinating Center (RCC) for the Consortium. The Duke RCC will leverage extensive institutional
resources and expertise at Duke University to provide administrative leadership and research
coordination to ensure seamless operations of the Consortium and successful conduct of Consortium
studies; support rigorous data collection, data management, and data analysis for Consortium
studies; and foster research collaboration, capacity-building, and workforce diversification in kidney
health equity research. Three closely integrated cores will lead the core activities of the RCC. The
Administrative and Coordination Core will provide administrative, operational, and logistical support to
the Consortium, including coordinating meetings, developing a secure web-based communications
and collaboration platform, supporting program management and regulatory submissions,
administering an opportunity pool for ancillary studies, and continually evaluating and enhancing
Consortium operations. The Data Management and Analysis Core will contribute to the final design of
Consortium studies, provide data monitoring for multi-site Consortium studies, and support statistical
analysis for multi-site Consortium studies and pooled analyses of common data elements across the
Consortium. The Collaboration and Community Engagement Core will foster a vibrant and
collaborative research community within and beyond the Consortium by facilitating discussion at
Consortium meetings and workshops, supporting dissemination of Consortium results to the broader
research and lay communities, integrating selected NIH career development awardees in relevant
Consortium activities, and exposing early-career trainees from underrepresented groups to kidney-
focused structural racism scholarly work in order to successfully implement health equity research
and interventions. Together, the multidisciplinary RCC team will ensure the successful completion of
multiple intervention trials targeting disparities in kidney health and build a diverse and sustainable
community of researchers and community partners focused on improving kidney health in
marginalized populations.

Public health relevance
PROJECT NARRATIVE Structural racism is an important contributor to disparities in kidney disease. The proposed research coordinating center will support a research network and multiple clinical trials focused on addressing structural racism to reduce disparities in kidney health and disease.